CCR Education and Outreach

This project is important because it provides the public, Congress, and scientific communities with an understanding of the research advances that are being made with U.S. tax dollars and about opportunities to participate in clinical research. Critical components of this project include the publication and dissemination of research results and clinical trials outreach to the public and referring physicians. A third component is ensuring clear and transparent communications to the CCR internal community to facilitate efficient work and compliance with policies and procedures. Accomplishments this year include Production of the Milestones publication online, which highlights CCR's most noteworthy research advances; dozens of summaries of important peer-reviewed journal papers written for the lay public; announcements of new clinical trials opening and other activities were shared via the website: https://ccr.cancer.gov/news. The office worked with NCI's Office of Communications and Public Liaison to disseminate press releases and to inform the media about the research progress being made within CCR. CCR also disseminated information to the public through social media including LinkedIn and through GovDelivery. The office also worked collaboratively with many other NCI and NIH organizations, including the Division of Cancer Treatment and Diagnosis; Division of Cancer Epidemiology and Genetics; Office of Congressional and Government Relations; NCI at Frederick; the NIH Office of Intramural Research; and the NIH Clinical Center. The office supported visits by interested Congressional staff, advocates, scientific collaborators and dignitaries.